A Validation Study of Satellite-based Measure of Artificial Light at Night for its Application in Epidemiological Research

PROJECT SUMMARY
Artificial light at night (ALAN) is an emerging environmental. Growing research has linked higher ALAN
exposures to a broad range of diseases, including cardiometabolic conditions. To date, the vast majority of
epidemiological studies on health effects of ALAN relied on satellite data to measure ALAN. Although satellite
data are publicly available and provide estimates across wide geographic areas and large populations, it remains
unknown to what degree satellite-based measures reflect individual-level exposures. To the best of our
knowledge, only two published studies compared satellite-based with individual-level ALAN measures and
reported weak or no correlation between the two. However, these studies have several limitations: First,
previous studies had small sample sizes with low ALAN levels, which limited statistical power and generalizability.
Second, previous studies lacked diversities required for in-depth analysis in subpopulations with different
geographic, demographic, socioeconomic and lifestyle characteristics, all of which may influence how well
satellite data capture individual-level exposures. Third, none of the previous studies investigated the validity of
satellite data in the context of studying exposure-outcome associations in epidemiological research. We propose
to conduct a comprehensive validation study of satellite-based ALAN measure in a large, diverse and nationally
representative sample, the National Health and Nutrition Examination Survey (NHANES, 2011-2014). The
NHANES collected individual-level ALAN measures using wrist monitors and residential addresses that can be
linked to satellite data, as well as information on a wide range of health outcomes, including cardiometabolic
markers that have been consistently linked to ALAN. Aim 1. Compare satellite-based ALAN measures with
individual-level measures in the overall sample. Aim 2 Compare satellite-based ALAN measures with individual-
level measures in subgroups with different sociodemographic, lifestyle and geographic characteristics. Aim 3
Compare the associations between cardiometabolic outcomes and ALAN using satellite-based or individual-level
measures. In the past years, we have worked diligently to obtain approval from the National Center for Health
Statistics to access the restricted address data, acquired and linked satellite data to NHANES, and determined
the relevant individual-level ALAN measures for comparison with satellite measures. With focused aims to
address gaps in existing research, our study will be the first large-scale validation study of satellite-based
ALAN measures in a nationally representative and diverse dataset with relevant health outcomes. It is
innovative because it will not only provide an overall measure of validity but will also examine whether and how
satellite data validity is influenced by population characteristics, and answer the critical question regarding the
utility of satellite data in assessing ALAN-health associations in epidemiological research. Thus, our study is
significant because it will provide key information for better interpreting existing epidemiological evidence,
guiding the design of future studies, and enhancing the translational value of ALAN research.

Public health relevance
PROJECT NARRATIVE Artificial light at night (ALAN) is an emerging environmental hazard with important public health implications, however, there is a contentious debate about how well satellite data commonly used in epidemiological studies can serve as a measure of ALAN exposure at the individual level. Our study will be the first large-scale validation effort of satellite-based ALAN measures in a nationally representative and diverse dataset with relevant health outcomes. We expect our study to provide crucial information for better interpreting existing epidemiological evidence, guiding the design of future studies, and enhancing the translational value of ALAN research.